Training in the Science of Co-Occurring Disorders

This renewal application proposes a plan to sustain and enhance a unique training program in an emerging
area of trans-disciplinary research, co-occurring substance use and other psychiatric and medical disorders
(COD). The need for this scientific focus is vital given that COD are more the norm than the exception among
those with addictive disorders. The philosophy of this program charges that to effectively impact the problems
of addiction and other common psychiatric and health disorders, one must be fully aware of their co-existence,
etiologies, phenomenology, and clinical manifestations. Our evolving program leverages unique resources and
opportunities available at Dartmouth. Five diverse research groups (Center for Technology and Behavioral
Health, Department of Psychological and Brain Sciences, Norris Cotton Cancer Control Research Program,
the Department of Psychiatry’s Addiction Research Program, and the Program of Experimental and Molecular
Medicine-Neuroscience) provide COD-focused opportunities in behavioral and neurobiological mechanisms,
behavioral and pharmacological treatment development, technology-assisted innovations in assessment and
treatment delivery, implementation science, and health services and policy. Training faculty include MD and
PhD investigators with strong histories of training young scientists and outstanding records of extramural
funding to support their research programs. Currently our T32 faculty have 24 NIH-, 3 NSF-, and 1 PCORI-
funded projects. During the first 4 years of this program (the initial cycle of funding), our training slots have
remained at capacity with high quality trainees, and we have now trained or are in the process of training 4
predoctoral and 7 postdoctoral T-32 funded trainees and two other trainees who participated in our program
but were funded by other sources. These trainees have authored 75 peer-reviewed publications related to their
training activities and were first author on 45% of these. Our trainees have presented their research at many
national and local scientific conferences, and all but two have completed capstone projects in a secondary
area of interest with an alternative mentor. All the trainees who have or are about to complete the program
continue in research intensive positions or have continued in the next step of research training towards
becoming independent research scientists. Our evaluation process has yielded highly positive feedback, and
also resulted in planned enhancements to our training program. This renewal application proposes to maintain
an active census of 3 predoctoral and 4 postdoctoral trainees. We have developed a revised a recruitment plan
that takes advantage of new Dartmouth initiatives to address our continued difficulty attracting and enrolling
underrepresented minorities to the program. Overall, the first cycle of T32 funding has resulted in the
successful development and implementation of a vigorous training program that is effectively preparing young
scientists to engage in collaborative and transdisciplinary research that embraces and addresses the co-
existence of addiction and other psychiatric and health disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposed training program is highly relevant to the public health because it will continue to train new cohorts of scientists to conceptualize and research addiction from a primary perspective that substance use disorders most often co-occur with other types of psychiatric and medical disorders. Moreover, the diversity of our faculty’s research programs combined with the structure of the training program assures that trainees learn to embrace and apply transdisciplinary approaches to understand the problems they seek to address.